STRUCTURAL STUDIES ON BIOACTIVE NATURAL PRODUCTS

Research on the isolation and structure determination of several unknown, biologically active natural products is proposed. All of the structures would be unequivocally established by X-ray diffraction. Compounds from marine organisms, higher plants and microorganisms will be examined. Some specific targets are: 1. K112, K203 and K205, uncharacterized compounds with potential as chemotherapeutic agents in cancer treatment, 2. leucogenenol, a mammalian compound that stimulates wide spectrum myeloid differentiation from bone marrow precursors, and is capable of completing the peripheral T-cell differentiation cycles in the absence of the target thymus organ, 3. ciguatoxin, brevetoxin A and another, unnamed dinoflagellate toxin which appear to be highly unusual polyethers, 4. small antibiotic molecules from Tubastria spp., Uvaria spp. and Pseudopterogorgia bipinnata, 5. the bisintercalating antitumor antibiotic BBM-928A and its interactions with nucleic acids.